Task C14: Advancing Human Lung Microphysiological Systems to Model Coronavirus Infection and Test Candidate Countermeasures

This contract provides for the development and standardization of difficult-to-source reagents that require the use of nontraditional animal models of infectious diseases.